Neural circuitry of distress tolerance

Abstract
In addicts, the psychological distress associated with withdrawal can lead to resumption of drug taking (relapse)
to ameliorate this state, at the expense of more beneficial goals. Indeed, an inability to tolerate the psychological
distress experienced while in pursuit of a challenging goal (referred to as low distress tolerance, DT) is
characteristic of substance users and is predictive of eventual relapse. In clinical models of DT, subjects engage
in progressively difficult behavioral tasks that eventually become virtually impossible to complete correctly.
Subjects are given the option to quit the task early, and DT is defined as the duration of time the subject spends
on the very difficult task before quitting. Thus, DT measures the ability of the individual to persist in challenging
goal-directed behavior in the face of increasing psychological distress, and has recently become a focal point of
treatment strategies for substance use disorders. However, few studies have investigated the causal relationship
between DT and relapse or its underlying neurocircuitry due to the difficulty in directly assessing these
relationships in clinical populations. To address this, the Carelli lab recently developed a rodent model of DT
and demonstrated that low DT in rats predicted high cocaine-seeking behavior. Critically, this only held true
when DT was measured following extended abstinence from drug, a period of time shown to result in numerous
neuroadaptations and increased drug seeking in rodent models. The overall objective of this application is to
use our rodent model of DT to examine underlying neural circuits mediating DT, and their causal role in this
behavior. Since the dorsolateral prefrontal cortex exhibits dampened activity in cocaine users during the DT
task, proposed studies will investigate the role of its rodent homologue, the prelimbic cortex (PrL), in DT.
Additionally, PrL projections to the nucleus accumbens core (NAc core) and PrL afferents from the insula (INS)
are also of interest, given their role in craving, drug-seeking, negative affect, and task persistence. Thus, using
our rodent model of DT, the present application will examine the PrL-NAc core (Aims 1 & 2) and INS-PrL (Aims
3 & 4) circuits during DT throughout various stages of cocaine self-administration and abstinence. In Aim 1, I will
employ electrophysiological methods to examine how PrL or NAc core activity, or their connectivity, during DT
is altered by a history of cocaine and predicts cocaine seeking and taking. In Aim 2, I will use optogenetic tools
to investigate if activation of the PrL to NAc core pathway can reverse the deficits in DT induced by prolonged
abstinence from cocaine self-administration. In Aim 3, I will use similar electrophysiology methods to examine
how INS activity and/or INS-PrL connectivity during DT is altered by a history of cocaine and predicts cocaine
seeking and taking. Lastly, in Aim 4, I will determine if optical activation of the INS to PrL pathway can reverse
the deficits in DT induced by abstinence from cocaine self-administration. Collectively, these studies will provide
insight into neural circuits underlying DT, a recent focus of promising treatment strategies for humans suffering
from substance use disorders.

Public health relevance
Project Narrative The inability to tolerate the psychological distress experienced while in pursuit of a challenging goal (referred to as low distress tolerance, DT) is characteristic of substance users and is predictive of eventual relapse. The overall objective of this application is to employ a rodent model of DT developed in our laboratory to examine underlying neural circuitry mediating DT. Understanding neural circuits mediating DT are timely and highly significant since targeting DT has recently become a promising treatment strategy for humans suffering from substance use disorders.